MSK Computational Biology Summer Program

R25 MSK Computational Biology Summer Program: Project Summary / Abstract
The Memorial Sloan Kettering Cancer Center (MSK) Computational Biology Summer Program (CBSP) is a
cancer education research experience that will enable 15 computer science and applied math undergraduates
per year to apply their computer science skills to cancer-based laboratory and clinical research under the
mentorship of MSK faculty. Program participants will work with mentors in laboratories centrally involved in
basic and clinical research, with a computational focus to their work. CBSP trainees will also attend
educational lectures, journal clubs and a wide range of seminars, including several focused on professional
development. They will learn how to blend these lessons to present their work in a capstone showcase of their
work at the conclusion of the 10-week internship.
We anticipate that for some of the CSBP participants, this summer experience will be their first exposure to
cancer biology, biomedical concepts, and laboratory research. By providing them with a concentrated and
intense exposure to cancer biology, we will ensure that they will have the proper understanding to apply their
computational skills to help develop novel methods and mine data for insights toward mechanistic and
therapeutic advances. A key goal of this program is to increase the students’ awareness of and interest in
careers as computational biologists. Through strategic recruitment of computer science and computational
biology undergraduates and exposure to carefully selected mentors and research topics, the CBSP will provide
a path toward development of computational biologists capable of informing the vanguard of cancer biology.
The CBSP will enhance the students’ knowledge about cancer, genomics, and academic biomedical research,
and will foster interest in careers in oncologic fields by pursuing the following Specific Aims:
1. Engage computationally fluent undergraduate students with little previous exposure to biology in
innovative scientific research projects that address cause, diagnosis, prevention, and treatment of
cancer
2. Provide CBSP students with additional mentorship to promote their professional development within
computational oncology and biology in order to foster the trainees’ interest and engagement in
academic computational cancer research
Through the exposure that the CBSP will enable, we expect to shape the undergraduates’ perception of
computational biology applied to cancer research such that many will pursue graduate studies in this field.

Public health relevance
R25 MSK Computational Biology Summer Program: Project Narrative The MSK Computational Biology Summer Program (CBSP) aims to train the next generation of computer science savvy students in cancer biology. Biologists are trained to form a hypothesis and provide data to support it, but in the current big data era, many can’t find the insights they seek in the vast troves of data they’ve collected. CBSP participants, through exposure to cancer biology topics, can use their skills to develop new tools and mine big data towards finding the next generation of cancer therapeutics, patient diagnostics, and furthermore, can uncover novel biological and mechanistic insights into cancer.